Interdisciplinary and Inclusive Predoctoral Training in Molecular, Cellular, and Biochemical Sciences

Abstract of Parent Award:
Solving the complex problems in human health and modern biology represents a major challenge
for those who will lead biomedical research in both the near and long-term future. The core
disciplines of our training program, molecular biology, cell biology, and biochemistry, have led the
way in development of innovations that are currently driving life sciences research and
applications today. It is imperative that US life scientist training programs evolve to meet the
demand for a diverse group of leaders who are trained in rigorous and transparent implementation
and reporting of quantitative analysis of biological data. We recognize this will require a change
in training culture that focuses on a high standard of professional development for trainers and
trainees. The objectives of this predoctoral training program are to: (1) Build and sustain an
equitable and inclusive training environment for an increasingly diverse group of PhD students.
(2) Integrate training in the design and implementation of rigorous and transparently reported
experimentation throughout the program. (3) Integrate training in quantitative and computational
approaches throughout the training program. (4) Integrate career exploration and student
professional development throughout the program.
Faculty trainers in the MCB Graduate Program are accomplished scientists who are drawn from
11 Departments at Brown University and the Warren Alpert Medical School. The mission of the
MCB Graduate Program is to train the next generation of leaders in biomedical research to probe
the molecular mechanisms of cellular and biochemical processes by building and sustaining an
equitable and inclusive training environment in which a diverse group of PhD students will
successfully gain quantitative, conceptual, technical, and professional skills that will allow them
to conduct the rigorous and reproducible research that interdisciplinary life science demands.
The MCB Graduate Program admits 8-12 students per year based on both their research and
academic potential. During the first or second year of graduate study, 4 trainees will be selected
from the ~20 eligible MCB graduate students for appointment to the training grant on the basis of
their potential for success in research; funds to support 8 trainees per year are requested.

Public health relevance
Project Narrative: This supplement will fund a mentor training developer/coordinator who will greatly expand mentor training across the Brown University Division of Biology and Medicine and have broader impacts because new mentor-mentee case studies will be disseminated nationally through the CIMER network.